Studying Neuronal Proteostasis During Aging and AD with Novel Protein Tagging Tools

Project Summary
A causal hallmark of brain aging and Alzheimer’s Disease (AD) is loss of proteostasis, the maintenance of
proteome health through several processes, including protien degradation/clearance (hereafter, ‘turnover’).
Neuronal proteostasis is exceptionally vulnerable during aging and AD as evidenced by the accumulation of
dysfunctional or toxic neuronal proteins, such as pTau and Aβ, causal for neuron dysfunction and degeneration.
While there is an appreciation for the role of dysregulated proteostasis in brain aging and AD, much remains to
be understood about the dynamics of neuronal protein turnover (NPT), consequences of aberrant NPT,
and NPT regulators during aging and AD. I hypothesize that NPT is compromised with aging and AD,
ultimately worsening age and AD phenotypes, and NPT is at least partially regulated by lysosomal biology and
microglia. I am uniquely positioned to address my hypotheses thanks to my establishment of a new in vivo model
of bioorthogonal non-canonical amino acid tagging (BONCAT). BONCAT permits the tagging of newly
synthesized proteins with an azide-bearing phenylalanine (AzF) in a cell-specific manner. Tagged proteins can
be pulled down and analyzed by mass spectrometry (MS). When AzF is provided to BONCAT mice in a pulse-
chase administration scheme and mice are sacrificed at different time points in the chase, tagged proteins can
be pulled down and their reduction over the chase/time, representative of turnover, can be examined. I have
performed this experiment in young and aged neuronal-BONCAT mice, finding >800 relatively longer-lived
proteins (RLLPs) with aging, many of which are in pathways of neurodegeneration. Here, I propose to perform
an identical experiment in AD models, compare the results to aging, and use an in vitro human transdifferentiated
neuron model in conjunction with targeted protein degradation to determine the pathological consequences of
select RLLPs common to aging and AD. I will additionally combine BONCAT with a novel lysosome
immunoprecipitation (IP) method, LysoTag, to understand the causality of autophagic/lysosomal dysfunction in
age/AD NPT aberrations. Lastly, I will apply BONCAT to understand how microglia regulate NPT by (1) examining
neuronal protein uptake by microglia and (2) determining how deletion of Trem2, a microglia-specific AD risk
factor, alters NPT. Cumulatively, the proposal will address what NPT changes occur with aging/AD, how the
changes affect neuronal health and pathology, and how the lysosome and microglia act as intrinsic and extrinsic
regulators of NPT. Findings will hold promise to identify new targets to promote healthy brain aging. Through
continued training with the K99/R00 award, I will learn new methodologies (MS acquisition/analysis; lysosome
IP; targeted protein degradation) and concepts (proteostasis; autophagy) and participate in critical professional
development workshops/classes. The research and training proposed herein will empower me to be a successful
and impactful independent researcher and mentor.

Public health relevance
Project Narrative Dysregulated proteostasis, particularly protein turnover, is a hallmark of brain aging and Alzheimer’s Disease (AD), but many details remain to be understood about protein turnover due to previous technical limitations. In this proposal, leveraging new protein-tagging methodologies, l aim to (1) identify aberrations in neuronal protein turnover dynamics and their functional consequences during aging and AD and (2) understand a neuron-intrinsic regulator of protein turnover (autophagy/lysosome) and a neuron-extrinsic regulator of neuronal protein turnover (microglia) during aging and AD. The findings from my studies will substantially increase our basic biological understanding of neuronal proteostasis/protein turnover during brain aging and AD, and ultimately identify new targets to promote resilience to brain aging and AD.